Mechanisms of Fatigability and the Protective Effects of Exercise in People with Diabetes

Abstract
Pre-diabetes (Pre-D) is characterized by elevated glycated hemoglobin and plasma glucose and is a clinical
precursor to type 2 diabetes mellitus (T2D). Pre-D currently affects ~90 million Americans. Both Pre-D and T2D
are highly associated with cardiovascular disease and among the top five causes of mortality worldwide. Exercise
is the cornerstone of management and is most efficacious during the Pre-D stage when glycemia is below the
diabetic threshold. However, excessive fatigability during exercise (i.e., exercise induced reductions in force or
power of the limb muscles) limits exercise performance in people with Pre-D. Our laboratory demonstrated that
(1) across the diabetic spectrum, people with Pre-D and T2D have greater fatigability of limb muscles than
controls due to mechanisms within the muscle, and (2) fatigability in people with T2D was associated with a
reduced blood flow to the exercising muscle. It is unknown, however, if people with Pre-D have impaired vascular
function and oxygen delivery that leads to an increased fatigability. Our central hypothesis is that impaired
vascular function impedes blood flow and blunts subsequent oxygen delivery to skeletal muscle during exercise,
resulting in excessive fatigability of limb muscles in people with Pre-D. A unique and translational aspect of this
proposal is the quantification of the vascular responses (macro- and micro-vasculature) to fatiguing exercise and
exercising training at different sites along the vascular tree, including, in feed arteries (doppler ultrasonography),
isolated skeletal muscle arterioles (extracted from muscle biopsy), capillary perfusion (near infrared
spectroscopy, NIRS) and capillary density (from muscle biopsies). Aim 1 will determine if vascular dysfunction
is a mechanism for excessive fatigability in people with Pre-D. Aim 1.1 will compare leg blood flow and skeletal
muscle oxygenation in response to dynamic fatiguing exercise between people with Pre-D, healthy controls and
T2D. Groups will be matched for age, sex, body mass index and physical activity levels to determine disease-
related vascular function and fatigability rather than inactivity-related changes across the diabetic spectrum.
Skeletal muscle blood flow through the femoral artery will be quantified with ultrasonography and skeletal muscle
oxygenation with NIRS during a dynamic fatiguing knee extension exercise. Aim 1.2 will determine endothelial
vascular function at macro- and micro-vascular levels in people with Pre-D and T2D. Flow-mediated dilation will
be assessed in vivo in the femoral artery using ultrasonography and in isolated arterioles extracted from the
vastus lateralis muscle biopsies. Aim 2 (a clinical trial) will assess the vascular mechanisms for improved blood
flow and fatigability in response to dynamic exercise training with blood flow restriction in people with diabetes.
People with Pre-D and T2D will perform 8 weeks of unilateral resistance training in which one leg is exercised
with freely perfused conditions and the other leg with blood flow restriction. Thus, blood flow restriction and
resistance training will be used as a probe to further understand the mechanisms of fatigability along the vascular
tree in people with Pre-D and T2D, and test training strategies to improve fatigability in this population.

Public health relevance
Project Narrative Pre-diabetes (Pre-D) is a precursor to type 2 diabetes (T2D) and characterized by increased exercise fatigability of lower limb muscles, that can impede exercise performance. The cause for the increased fatigability in people with Pre-D is not known. Given the profound vascular disease present in people who have had uncontrolled diabetes for several years, we will determine whether dynamic, fatiguing contractions of the lower limb muscles in people with Pre-D are limited by vascular dysfunction at multiple levels along the vascular tree including the artery, arteriole, and/or capillary. Furthermore, a novel exercise training regime involving blood flow restriction to the exercising limb will be used as a probe to further understand the vascular mechanisms for increased fatigability in people with Pre-D and T2D. The long-term goal is to better understand what limits exercise and functional performance in people with diabetes to help develop targeted, more effective exercise programs.